Interpretable and Adaptable Graph Neural Networks: Modeling Metapopulation Dynamics of Vaccine-Preventable Childhood Infections

Project Summary/Abstract
The overarching goal of this proposal is to contribute to the fundamental understanding of the spatiotemporal
transmission dynamics and control of vaccine-preventable childhood infections. The central scientific premise
motivating this project is that integrative modeling approaches, effectively combining traditional mechanistic
models and machine learning techniques, have the greatest potential to address the persisting methodological
challenges in fully characterizing and accurately predicting the complex spatiotemporal transmission dynamics
of childhood infections. We hypothesize that such integrative approaches can overcome the limitations in the
inferential and predictive capabilities of existing models, precisely disentangling and predicting the influence of
the underlying drivers of transmission dynamics. As such, they can be leveraged to define the most effective
control strategies, including vaccination.
Three specific aims are proposed. Aim 1: Develop and validate a highly interpretable and predictive modeling
framework by deeply integrating graph neural networks with compartmental models. We deliberately develop a
highly flexible and generalized graph neural network-based approach to incorporate the underlying network of
infection transmission among interconnected populations (or a metapopulation) such as a collection of
neighboring towns. We propose new inferential approaches leveraging Approximate Bayesian Computation to
facilitate the integration. Aim 2: Develop a comprehensive software platform to facilitate implementations of our
models developed in Aim 1, and to promote and catalyze the development and adoption of machine learning
modeling research in the community of infectious disease modeling. Aim 3: Test our developed modeling
framework using rotavirus and measles as examples and illustrate how our trained models can be used to
guide efficient adaptive vaccination and control strategies for rotavirus and measles in the US. Rotavirus and
measles are example types of vaccine-preventable diseases, endemic and re-emerging, respectively. Results
of this project will also broadly lend valuable insights into future studies (e.g., designing effective vaccination
programs) for other vaccine-preventable diseases (VPDs), such as RSV and norovirus which are expected to
become VPDs soon.

Public health relevance
Narrative Despite decades of theoretical and empirical work, the problem of fully understanding and accurately predicting the complex spatiotemporal dynamics of childhood infections in the context of vaccination remains unresolved. The key to a solution lies in enabling a deep understanding of the intricate geometry of infection spread among a network of spatially interconnected populations (i.e., a metapopulation). This project develops a new modeling framework—effectively combining the strengths of mechanistic models and graph neural networks— to provide such a solution that is also key for guiding effective controls, particularly in optimizing vaccination programs for current and future vaccine-preventable childhood infections.